Proyecto Vida: Developing an HIV, HCV and opioid use MOST intervention for persons who inject drugs along the Texas-Mexico Border

Project Summary
The proposed K01 supports the training of a Chicana epidemiologist in intervention science and phylogenetic
analysis to address the co-occurring and mutually reinforcing epidemics of HIV, hepatitis C (HCV) and opioid
use among Latino persons who inject drugs (PWID) living along the Texas-Mexico Border. The study location,
Ciudad Juárez, Mexico, is largely underserved and associated with a high prevalence of HCV (>80%) and HIV
(>10%) among the 10,000 Latino PWID who largely inject opioids (>90%).The proposal draws from the
multiphase optimization strategy (MOST), an intervention framework for developing and testing multi-component
interventions within real-world constraints. Career development activities are centered around the MOST
Preparation Phase that includes optimizing four intervention protocols, developing a testable conceptual model,
and conducting a 2-to-3 factorial experiment to assess the feasibility and acceptability of a future larger trial.
Intervention components and outcomes include (a) peer navigation for to increase HCV treatment engagement
and cure (HCV-PN), (b) HIV testing and PrEP education (HIVT/PrEP) to increase quarterly HIV testing and PrEP
knowledge, (c) opioid agonist treatment (OAT) to decrease opioid use , and (d) syringe services to reduce sharing
injection equipment. A novel strategy toward HCV and HIV elimination among PWID is to merge intervention
science with phylogenetic testing to reveal subgroups experiencing suboptimal HCV care outcomes and track
transmission networks. Career development activities will include didactic training in intervention science and
phylogenetics, with applied learning activities conducting a small-scale MOST trial paired with HCV
phylogenetics. Phylogenetic testing is a powerful mechanism for distinguishing between HCV treatment failure
and reinfection, which can lead to resistance associated substitutions. Phylogenetic results can then feed into
the HCV-PN intervention to address the needs of PWID sub-groups experiencing HCV sub-optimal care who
need additional support. The proposed K01 specific aims, mentorship, training plan, community partnerships,
and prior training will launch this early-stage investigator’s independent research career using modern
intervention science methods integrated with biomarkers. Finally, the proposed research activities will pave the
way for a larger R01-funded study and aligns with NIDA’s Strategic Plan 2022-26 of addressing of co-occurring
epidemics, applying novel interventions strategies, and accelerating the implementation of evidence-based
strategies in real-world settings that benefit underserved communities.

Public health relevance
Project Narrative The proposed K01 career development and research activities merge intervention science with phylogenetic analysis to address the co-occurring epidemics of HIV, hepatitis C, and opioid use among people who inject drugs along the Texas-Mexico Border. Research activities are guided by the Multiphase Optimization Strategy (MOST) Preparation Phase including formative intervention development activities and a feasibility and acceptability trail using a factorial experiment design. Our trial will lay the foundation for a full-scale MOST trial in the future that tests four intervention components that aim to reduce drug use, promote HIV prevention, and increase HCV cure, with phylogenetic analysis conducted in parallel to determine sub-optimal HCV treatment outcomes and transmission networks. Proposed training and research activities will provide a platform to launch an early-stage investigator’s long-term career in intervention science and novel biomarker research.